SAMHD1 mediated dNTP regulation and HIV in myeloid cells

Project Summary
Lentiviruses including HIV-1 infect both activated/dividing CD4+ T cells and terminally-
differentiated/nondividing myeloid cells (e.g., macrophages and microglia) during the course of their
pathogenesis. The reverse transcription of lentiviruses consumes dNTP substrates provided from the infected
host cells. However, it was predicted that nondividing cells such as macrophages should contain limited dNTP
pools. Indeed, we previously reported that human primary monocyte derived macrophages harbor extremely
limited dNTP levels (20-40 nM), compared to activated CD4+ T cells (1-5 µM), and this limited dNTP level in
macrophages restricts HIV-1 replication. We also reported that the host SAM domain and HD domain
containing protein 1 (SAMHD1), which hydrolyzes dNTPs and is abundant in macrophages, is responsible for
the low dNTP levels and the restricted HIV-1 replication in macrophages. Recently, we discovered two novel
regulatory circuits of SAMHD1 mediated dNTP metabolism that can operate in nondividing myeloid cells
for dNTP depletion and HIV-1 restriction. In this proposal, we propose to elucidate virological, molecular and
structural natures of these regulatory circuits of SAMHD1-mediated dNTP depletion in nondividing myeloid
cells. In Aim 1, we will explore our hypothesis that SAMHD1 not only hydrolyzes dNTPs but also directly
suppresses the RNR-mediated dNTP biosynthesis by binding to RNR in macrophages. Our hypothesis
predicts that Vpx can rapidly elevate dNTP levels in macrophages following SAMHD1 degradation by
simultaneously removing a suppressive regulator of RNR mediated dNTP biosynthesis. Indeed, we recently
observed the direct binding of SAMHD1 to RNR R1 subunit, supporting this hypothesis. Here, we will
investigate this negative dNTP metabolic regulatory circuit mediated by the SAMHD1-RNR interaction for
dNTP depletion and HIV-1 restriction in nondividing myeloid cells. In Aim 2, we hypothesize that cellular PP2A-
B55 phosphatase is a key positive regulator of SAMHD1 in nondividing myeloid cells that can keep SAMHD1
un-phosphorylated and enzymatically active for dNTP depletion and HIV-1 restriction. Indeed, we observed the
interaction of SAMHD1 with B55 regulatory subunit of PP2A in nondividing myeloid cells, supporting this
hypothesis. Here, we will investigate the roles of SAMHD1-PP2A interaction in the negative regulation of dNTP
metabolism and HIV-1 restriction in macrophages. In Aim 3, we propose to investigate the structural and
molecular natures of the SAMHD1 interactions with RNR and PP2A that contribute to dNTP depletion and HIV-
1 restriction in nondividing myeloid cells by employing cryo-EM and X-ray crystallography. Overall, we will
explore the unique SAMHD1-mediated dNTP metabolic regulatory circuits in nondividing myeloid cells, which
are engineered by two distinct regulators, and this proposal aims to discover new and better antiviral concepts
specifically targeting HIV-1 in long-living myeloid reservoirs that contribute to HIV-1 persistence.

Public health relevance
Health Relevance HIV-1 infection to non-dividing myeloid cells, such as macrophages and microglia (brain macrophages), contributes to HIV-1 pathogenesis. Particularly, HIV-1 infected macrophages serve as a key long-living viral reservoir that persistently produces viral progenies even during the course of intense antiviral therapy. This application attempts to elucidate novel regulatory circuits of a host defense mechanism executed by a host restriction factor, SAMHD1, that kinetically delays multiple steps of HIV life cycle in nondividing viral target cell types, ultimately providing new anti-HIV target strategies that effectively suppress HIV-1 life cycle in non- dividing myeloid cells that contribute to HIV-1 persistence and neuro-AIDS.